Lead Optimization of a Therapeutic Candidate for Alzheimer’s Disease

Summary.
Overactivation of the hypothalamic-pituitary-adrenal (HPA) axis occurs in Alzheimer's disease
(AD) and dysregulation of the stress system plays a mechanistic role in the pathophysiology of AD
progression. This Phase I SBIR proposal will set the groundwork for the clinical development of a
first-in-class treatment for the long-term management for AD and other conditions characterized by
excessive activation of the HPA. While the stress response is essential for survival, it can become
dysregulated. Excessive activation of the HPA axis results in increased glucocorticoids release, which
has detrimental actions on the central nervous system, causing hippocampal and prefrontal cortex
functional impairments, and contributes to AD progression. Therapeutics to modulate the HPA axis
have been under research for decades. While glucocorticoid receptor antagonists have shown some
potential in the treatment of depression, they can be counterproductive when used long-term. CRF
receptor type 1 (CRF1) antagonists have also been studied extensively but have generally been
unsatisfactory due to side effects and limited efficacy on the HPA. Brain-penetrant CRF1 antagonists
can induce fear and aversion in humans, which may represent class side effects.
Thus, there is a considerable unmet medical need for identification of novel therapeutics to
normalize HPA hyperactivity that are effective and tolerable for long-term use. HPA hyperactivity is
believed to be a key pathogenic driver of AD and a validated therapeutic target. The present Phase I
SBIR seeks to advance the development of a novel therapeutic to reduce HPA hyperactivity and will
lay the foundations for the clinical development of a first-in-class therapeutic by optimizing a lead
candidate therapeutic for the long-term management of chronic hyperactivity of the hypothalamic
pituitary adrenal axis (HPA) for AD and other degenerative conditions.

Public health relevance
Narrative. Hypothalamic pituitary adrenal axis (HPA) hyperactivity contributes to the pathogenesis of Alzheimer’s disease (AD) as well as other neurodegenerative conditions. The present Phase I SBIR is aimed at the lead optimization of a new therapeutic for the treatment of AD and other medical conditions characterized by hyperactivity of the HPA. The present Phase I SBIR will lay the foundations for the development of a first-in-class therapeutic for the long-term management of chronic hyperactivity of the HPA for AD.